Pleiotropy of autism-associated chromatin regulators

ABSTRACT
Despite tremendous success in the reliable identification of more than 100 genes carrying large risk for autism,
an actionable understanding of the underlying biology has been elusive. Gene ontology analyses have
repeatedly emphasized an enrichment of genes encoding proteins involved in gene expression regulation and
neurotransmission. These areas have thus become a central focus for the field. However, ontology-based
analyses rely on incomplete knowledge of gene function and pleiotropy, and therefore, have the potential to miss
key aspects of the underlying biology. Indeed, our recent functional in vivo work has begun to elucidate additional
roles for proteins annotated as chromatin regulators in directly remodeling microtubules and the cytoskeleton. In
fact, there exists a “tubulin code” of post-translational modifications analogous to the “histone code” and ample
examples of canonical chromatin modifiers that directly modify tubulin to regulate microtubule dynamics. We
have generated preliminary data for five such autism-associated chromatin regulators suggesting that they have
dual functions, localizing to and functioning at microtubule-rich structures such as mitotic spindles, neuronal
growth cones, and cilia in a wide variety of cell types, including human neurons. Thus, we have developed the
bold hypothesis that autism-associated chromatin regulators have dual functions regulating both histones and
tubulins. To test this hypothesis, we will deploy innovative experiments leveraging unique advantages of the
Xenopus experimental toolkit, complemented by state-of-the-art proteomic profiling of tubulin post-translational
modifications in human cells. In doing so, this work will illuminate how high-confidence ASD-associated
chromatin regulators function at microtubules and the underlying post-translational modifications of tubulin that
mediate these effects. This will set the stage for future work exploring how these fundamental effects on tubulin
cascade to influence other neuronal processes like neuronal migration, axon outgrowth, dendrite formation,
synaptogenesis, and synaptic transmission. This work has the potential to completely reframe the potentially
relevant functions of these genes to autism biology, potentially bringing together the seemingly disparate
enriched annotations since microtubule dysfunction impacts neurotransmission. I am uniquely positioned to lead
this project, leveraging my experience in ASD genetics, proteomics, and innovative use of Xenopus to model
ASD gene variants and identify core underlying biology.

Public health relevance
PROJECT NARRATIVE Translating lists of disease risk genes into actionable understanding of underlying biology is a current major challenge in psychiatric disorder genetics, in part due to the inherent pleiotropy of the so-far identified genes. This proposal challenges the existing dogma that autism-associated chromatin regulators only function in regulating gene expression via the “histone code,” instead investigating their role in regulating microtubule dynamics via the “tubulin code.” This work has the potential to reframe our understanding of potentially relevant functions of these genes to autism, laying the groundwork for expansion into other disorders like schizophrenia where chromatin regulators are also enriched.